Administrative Core

Administrative Core
The Administrative Core (AC) will catalyze, coordinate, monitor, and evaluate research within the PACE. It is
also the hub for the coordination of the scientific interactions among the integrated cores and pilot projects that
comprise this P30 Center. The core will be directed by Robert H. Mach, Ph.D., Henry Kranzler, M.D., and Caryn
Lerman, Ph.D., the PIs of this P30 Center application who will also ensure that the research conducted in the
Pilot Project Core remains highly innovative and serves the programmatic interests of NIDA. Given the multi-
disciplinary structure of the individual cores comprising the PACE, a key component of the Administrative Core
is the Executive Committee, which consists of the PIs of the research cores and the pilot project core and other
key personnel involved in this center. This Executive Committee will meet on a monthly basis to provide financial
oversight and reports on the day-to-day operation of the individual cores in meeting the scientific objectives of
the pilot projects. Another key component of the Executive Committee will be scheduling of activities associated
with the planned preventive maintenance of the equipment and instrumentation in the Radiology Department
and the patient recruitment in the Clinical Core. The Administrative Core will also coordinate the activities of the
Internal Advisory Committee and the External Scientific Advisory Board. Another important function of the
Administrative Core is to enhance interdisciplinary team science and foster synergies among the pilot projects
and research cores, through coordination of scientific strategic planning and an annual all-day retreat (PACE
day), and fostering overall communication and alerting PACE investigators to emerging science and research
opportunities.